A Dual-Antigen NK Cell Engager to Overcome Ovarian Cancer Tumor Heterogeneity

ABSTRACT
Ovarian cancer remains the deadliest gynecologic malignancy, with a five-year survival rate below 50% and a
high likelihood of recurrence. Current treatment strategies, centered on surgical debulking and chemotherapy,
have shown limited advancements over the past several decades, underscoring the urgent need for novel
therapies. Immunotherapy holds immense promise in this context, as increased natural killer (NK) cell activity
has been correlated with improved outcomes in ovarian cancer patients. Unlike T cells, NK cells are inherently
non-antigen-specific, enabling them to respond to heterogeneous tumors without prior sensitization, while also
avoiding complications like graft-versus-host disease. Like T cells, however, NK cells activity is hindered by the
immunosuppressive tumor microenvironment. To overcome this, our lab has developed and rigorously tested
the Tri-specific Killer Engager (TriKE) platform, which enhance NK cell activity by simultaneously targeting
CD16 on NK cells, binding tumor-associated antigens, and delivering an interleukin-15 (IL-15) cytokine
domain. Together, the TriKE promotes NK cell migration, activation, proliferation, and sustained cytotoxicity.
However, as with any immunotherapy targeting only a single antigen, the therapeutic application of the TriKE
molecules could be hindered by the risk of antigen escape, particularly in ovarian cancer’s highly
heterogeneous tumor microenvironment (TME). To address this challenge, we have developed a dual-antigen
targeting NK cell engager platform. A Poly-Antigen Cytokine Complex (PACC), which binds to the TriKE’S
IL-15 domain, was made by linking IL-15 receptor subunit alpha (IL-15Rα) to a tumor-targeting antibody
domain. This innovative system combines the well-established benefits of TriKEs with targeting of a second
tumor-associated antigen. By simultaneously engaging B7H3 and CD133, the TriKE-PACC is designed to exert
greater immunologic pressure, reducing the likelihood of antigen escape and improving therapeutic efficacy.
Aim 1 will evaluate the ability of the TriKE-PACC to prevent antigen escape in vitro and in vivo using ovarian
cancer cell lines with CRISPR-modulated antigen expression to model antigen escape. Aim 2 will assess the
preclinical efficacy of the TriKE-PACC against patient-derived xenograft (PDX) models of ovarian cancer to
capture the full heterogeneity of clinical tumors. Together, these studies will establish the therapeutic potential
of the TriKE-PACC and provide a foundation for its clinical translation. By targeting a dual-antigen approach to
enhance NK cell immunotherapy, this project seeks to provide a novel treatment avenue for ovarian cancer
patients, particularly the unmet need of those with recurrent disease who currently lack effective therapeutic
options.

Public health relevance
PROJECT NARRATIVE A type of immune cell known as Natural Killer (NK) cells are associated with improved outcomes in ovarian cancer, a highly lethal disease. This project aims to test a recently developed immunotherapy designed to enhance NK cell activity and tumor-targeting, with the ultimate goal of bringing this new therapeutic into the clinic. The therapy directs NK cells to attack ovarian cancer by recognizing and binding two key proteins frequently overexpressed on tumor cells, offering a potential breakthrough in treatment.